The Molecular Basis of Allorecognition in Social Amoeba

DESCRIPTION (provided by applicant): Allorecognition is the ability of organisms to distinguish self from non-self, a common theme in many organisms and a central component in the evolution of multicellularity. In mammals, allorecognition is mediated by the Major Histocompatibility Complex (MHC), which is part of the immune system. The MHC facilitates identification of parasites in infection processes, and graft rejection in transplantation medicine There is evidence for the involvement of other proteins in graft rejection but there are very few model systems available to study these proteins. There are several allorecognition systems in non-mammalian systems, notably in marine organisms, but most of them are not genetically tractable. In the previous grant period we found an allorecognition system in the social soil amoeba Dictyostelium discoideum. The system is based on two proteins, TgrB1 and TgrC1 that share many properties with mammalian MHC proteins, but not their amino acid sequences. We found these trans-membrane proteins to be highly polymorphic in natural Dictyostelium populations and necessary and sufficient for allorecognition. Dictyostelium cells live as free amoebae in the soil when food is abundant but they aggregate into multicellular organisms when starved. Aggregation involves chemotaxis to extracellular cAMP and Dictyostelium is one of the best model systems for the study of chemotaxis, which is a central process in embryogenesis and in innate immunity. When Dictyostelium cells encounter cells that carry incompatible TgrB1 and TgrC1 during aggregation, they segregate from one another and form separate multicellular organisms. We propose that TgrB1 on the surface of one cell binds TgrC1 on the surface of an adjacent cell and that binding initiates a signal transduction cascade that alters cell behavior. We intend to test this hypothesis by performing allele replacement and protein-domain swapping experiments using different polymorphic alleles of the two genes. Our recent work also showed that allorecognition has an unexpected effect on chemotaxis. Many models of chemotaxis consider the process to be cell-autonomous, but our findings suggest a cooperative effect that requires interactions between cells of the same allotype. To study this revolutionary finding further, we will test the effect of allorecognition on specific aspects of chemotaxis and identify which of the well-studied chemotaxis modules is altered by allorecognition. We also propose to use transcriptome analysis and genetic suppressors to identify signal-transduction genes that integrate allorecognition. We already found several candidate genes, including chromatin remodeling components and protein kinases that are likely candidates in the process. We will study these genes in the context of allorecognition and chemotaxis and search for additional ones as well. Lastly, we propose to test the role of allorecognition in Dictyostelium development past the aggregation stage. We found that the tgrB1 and tgrC1 are enriched in prestalk cells so we propose to use conditional expression and chimeric aggregates to test the possible role of these genes in cell-type differentiation and tissue segregation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Allorecognition is the ability of organisms to distinguish self from non-self, a common theme in many organisms and a central component in the evolution of multicellularity. Chemotaxis is a process that allows motile cells to find their way using chemical cues in inflammation, embryonic development and other health-related processes. We have found an unexpected link between allorecognition and chemotaxis in one of the best model organisms for the study of both, and we propose to study the molecular, cellular and genetic properties that link these processes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In the previous grant period we discovered an allorecognition mechanism, which is mediated by TgrB1 and TgrC11 - a pair of polymorphic cell-cell adhesion proteins in the social amoeba Dictyostelium discoideum (2). Double-gene replacement experiments in this haploid organism showed that a pair of compatible tgrB1-tgrC1 alleles is necessary and sufficient for allorecognition (4). We now propose to study the molecular and cellular details of this process and how it affects chemotaxis and tissue formation during development. Starving Dictyostelium amoebae aggregate through cAMP-chemotaxis and form multicellular organisms with distinct differentiated tissues, but our published work has shown that the cells segregate into separate multicellular organisms if their tgrB1-tgrC1 allotypes do not match (2, 4, 5). Moreover, the amoebae fail to maintain the aggregated stage if either one or both of these genes is deleted or if one of them is replaced with a non-matching allele (4). More recently we found that incompatibility in the tgrB1-tgrC1 allotypes leads to profound defects in chemotaxis, suggesting that chemotaxis requires intercellular cooperation that has not been appreciated before, and that allorecognition has a previously unrecognized role in tissue formation and maintenance. We propose to test these possibilities by carrying out the following experiments. Specific Aim 1. Determine the role of allorecognition and cellular cooperation in chemotaxis. We will test the hypothesis that tgrB1 and tgrC1 have regulatory effects on directional sensing in chemotactic cells. We will use tgrB1-tgrC1- double null strains to test the possibility of negative regulation, and mixing cells with several different tgrB1-tgrC1 allotypes to determine the extent of positive regulation of chemotaxis. We will test these strains in pure populations and in chimerae with wild-type cells to measure the effects of allorecognition. We will test the strains for chemotaxis of single cells in artificial cAMP gradients and compare their performance to chemotaxis in aggregates to distinguish between cell-contact-dependent and contact- independent effects. We will use established reporters of cAMP chemotaxis (e.g. promoter-GFP fusions) to determine which of the known chemotaxis modules are specifically affected by allorecognition. We will use cytoskeleton markers (e.g. protein-GFP fusions) to test the effect of allorecognition on cell polarization. Specific Aim 2. Characterize the molecular interactions between TgrB1 and TgrC1. We will test the hypothesis that TgrB1 and TgrC1 function as a ligand-receptor pair. We will construct single-gene merodiploid strains that express one compatible allele, encoding either TgrB1 or TgrC1, in an otherwise incompatible background and mix them with a few compatible cells that carry reporter constructs, such as the early prespore marker cotB-GFP and the early prestalk marker tagB-GFP. Expression of the reporter would indicate that TgrB1, TgrC1, or both serve as ligands. We will use single-gene replacement strains that carry marker-GFP constructs in a similar paradigm to identify the receptor. We will also use a domain-swapping strategy in this system to identify protein domains that mediate the interaction between TgrB1 and TgrC1. Specific Aim 3. Molecular phenotyping of the allorecognition-mediated segregation process. We will characterize the molecular events that follow encounters between incompatible cells. We already used RNA- sequencing to identify more than 30 genes that were up-regulated in highly complex allotypic chimerae. We will generate reporter constructs (promoter-GFP fusions) of these genes and test their expression in single cells that are embedded in fields of double-gene replacement strains, tgrB1-tgrC1- double null cells, and in single-gene merodiploid strains both in pure populations and in allotypic chimerae. We have also identified 4 genetic suppressors of tgrC1- mutants - two chromatin-remodeling genes and two roco-kinase genes. We will test the effect of these suppressor mutations on the expression of the reporters and on the chemotactic behavior of cells during allorecognition. We also propose to expand and improve the transcriptomic analysis and the genetic suppressor screen. These experiments will help us identify signal transduction components that function in the allorecognition system. Specific Aim 4. Study the role of tgrB1 and tgrC1 in late developmental stages. tgrB1 and tgrC1 expression is enriched in prestalk cells after aggregation and cell-type differentiation. We will test the hypothesis that allorecognition plays a role in development after aggregation - in tissue morphogenesis and in terminal cell differentiation. We will disaggregate multicellular organisms with different allotypes at different developmental stages, mix the cells, allow them to re-aggregate, and monitor their cooperation and development. We will also generate conditional expression constructs of the tgrB1-tgrC1 promoter region and test the role of these genes at specific developmental stages by inactivating gene expression after the completion of aggregation. 1 Nomenclature: tgrC1 - gene, TgrC1 - protein, tgrC1- - null mutation, tgrC1QS4 - allele replacement (e.g. from strain QS4), tgrC1/GFP - promoter fusion, tgrC1-GFP - gene fusion; tgrB1 and tgrC1 were named lagB and lagC, resp.